A new humanized mouse model of chronic hepatitis B

PROJECT SUMMARY Chronic hepatitis B virus (HBV) infection is a significant global health problem because it substantially increases the risk for developing liver cirrhosis and hepatocellular carcinoma. Worldwide, more than 240 million people are chronically infected with HBV, and infection with this virus accounts for ~80% of all liver cancer. The human immune system can eliminate HBV from the liver, yet often fails to do so, especially in those who become infected at an early age. HBV persistence is due in part to immunoevasive tactics employed by the virus as well as host-driven immunosuppression of antiviral immune responses during chronic infection that serves to limit inflammation and immunopathology. Thus, therapeutic manipulation of the antiviral T cell response represents a promising method of treatment to cure the infection. However, the lack of suitable model systems in which to evaluate new immunotherapeutic approaches represents a critical barrier in the field. The overall goal of this proposal is to develop a new mouse model for HBV that unites the physiological relevancy of the human immune system with the convenience and reproducibility of genetically defined transgenic mice. Our general approach will be to combine well-characterized mouse models of HBV replication with a new strain of humanized mice whose immune systems can be efficiently reconstituted with T cells from HBV-infected patients. We will then test the hypothesis that engraftment of human immune cells in these mice will lead to an HBV-specific immune response in the liver, and that this response will reflect the disease status of the human donor. To evaluate our hypothesis, we will carry out two specific aims. First we will introduce HBV replication into the liver of a mouse strain that contains a number of knock-in gene-humanizations to improve the engraftment, differentiation, and maintenance of human hematopoietic populations in the animals. Second, we will engraft these mice with PBMC from acute-resolved and chronic HBV patients, and characterize how these immune cells traffic to the liver and respond to hepatocytes that produce HBV antigens. The intent of developing this model system is to provide new means for studying the human HBV immune responses in vivo. This will fill a critical unmet need, and we anticipate that this system will have wide application for both basic and translational HBV research to understand T cell functionality in chronic HBV infection, evaluate novel immunotherapeutic approaches, and identify determinants of HBV immunopathogenesis. Such analyses could have a substantial impact on the study and treatment of chronic liver infections in humans.

Public health relevance
PROJECT NARRATIVE Although preventable through vaccination, chronic hepatitis B virus infection remains a significant global health problem that affects an estimated 240 million people worldwide and substantially increases the risk for developing liver cirrhosis and hepatocellular carcinoma. While current therapies effectively control HBV replication, they typically do not cure chronic infection. This proposal aims to develop a new humanized mouse model system that can be widely employed to test new immunotherapeutic approaches for this disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Chronic hepatitis B virus (HBV) infection is a significant global health problem because it substantially increases the risk for developing liver cirrhosis and hepatocellular carcinoma. Worldwide, more than 240 million people are chronically infected with HBV, and infection with this virus accounts for ~80% of all liver cancer. The human immune system can eliminate HBV from the liver, yet often fails to do so, especially in those who become infected at an early age. HBV persistence is due in part to immunoevasive tactics employed by the virus as well as host-driven immunosuppression of antiviral immune responses during chronic infection that serves to limit inflammation and immunopathology. Thus, therapeutic manipulation of the antiviral T cell response represents a promising method of treatment to cure the infection. However, the lack of suitable model systems in which to evaluate new immunotherapeutic approaches represents a critical barrier in the field. The overall goal of this proposal is to develop a new mouse model for chronic HBV infection that unites the physiological relevancy of the human immune system with the convenience and reproducibility of genetically defined transgenic mice. Our general approach will be to introduce HBV replication into a new strain of "humanized" mice whose immune systems can be efficiently reconstituted with T cells from HBV-infected patients. We will then test the hypothesis that engraftment of human immune cells in these mice will lead to an HBV-specific immune response in the liver, and that this response will reflect the disease status of the human donor. To generate the model and evaluate our hypothesis, we will carry out two specific aims: Aim 1: Establish HBV replication in MISTRG-A2 mice to study human HBV-specific T cell responses. This Aim will focus on evaluating two complementary approaches for introducing HBV replication into the liver of humanized mice. The "MISTRG-A2" strain of humanized mice was developed by co-investigator Flavell, and contains a number of knock-in gene humanizations to improve the engraftment, differentiation, and maintenance of human hematopoietic populations. First, we will cross HBV 1.3-genome length transgenic mice that constitutively produce HBV in their livers with MISTRG-A2 mice. Second, we will initiate HBV replication in the liver of MISTRG-A2 mice through hydrodynamic injection of plasmids encoding the HBV genome. For both methodologies, the animals will be characterized for HBV antigen expression (liver HBcAg; serum HBeAg, HBsAg) and virus production (liver HBV DNA/RNA; serum viremia), and used in Aim 2 to study the human HBV-specific immune response. Aim 2: Characterize the human T cell response in MISTRG-A2 mice that produce HBV. In Aim 2, we will engraft the HBV.MISTRG-A2 mice with PBMC from 'acute-resolved' and 'chronic' HBV patients, and characterize how these immune cells traffic to the mouse liver and respond to hepatocytes that produce HBV antigens. After transfer of human cells, we will analyze the level of virus in the liver and serum, the extent of liver inflammation and injury, and the phenotype of HBV-specific T cells. More specifically, we will analyze expression of T cell inhibitory receptors, transcription factors associated with T cell exhaustion, T cell effector molecules and cytokines, and chemokine receptors. We will then compare the HBV-specific T cell responses in mice between those patient donors who have resolved acute infection, versus those who have become chronically infected. The intent of developing this model system is to provide new means for studying the human HBV immune responses in vivo. This will fill a critical unmet need, and we anticipate that this system will have wide application for both basic and translational HBV research to understand T cell functionality in chronic HBV infection, to evaluate novel immunotherapeutic approaches, and to identify determinants of HBV immunopathogenesis. Such analyses could have a substantial impact on the study and treatment of chronic liver infections in humans. To complete these Aims, we have assembled a research team with complementary expertise in HBV (PI Robek), T cell biology (co-investigator Kaech), humanized mice (co-investigator Flavell), mouse pathology (co-investigator Booth), and human studies (co-investigator Lim).